Assuring AI/ML-readiness of digital pathology in diverse existing and emerging multi-omic datasets through quality control workflows

Abstract
In an era of multi-omics, histology remains an essential approach for basic, translational, and clinical research
providing valuable, low-cost, and non-destructive information about tissue morphology. The adoption of whole
slide imaging (WSI) and digital pathology (DP) has led to large clinical and research repositories being
instantiated for computational data mining of image-based biomarkers associated with genotype, diagnosis,
prognosis, and therapy response. Importantly, data quality plays a critical role in the usage of these WSI,
especially when employing artificial intelligence (AI) and machine learning (ML) methods. Artifacts and batch
effects may arise at many points in the process from biopsy to digitization, and while several tools to detect them
have been developed, consistent application and reporting are lacking, with none being routinely applied in public
repositories. This leaves a unique opportunity to immediately provide added value to existing and future NIH-
supported datasets. This proposal sees a collaboration between Sage Bionetworks, experts in FAIR data sharing
and Team Science, and Dr. Andrew Janowczyk, a leader in automated quality control (QC) of WSI who has
spearheaded the development of an open-source DP QC tool, HistoQC. We propose to enhance the AI/ML
readiness of existing and future DP data by providing transparent, reproducible, reporting of detected imaging
artifacts and batch effects within NIH-sponsored datasets in an automated fashion via the extension of our
existing QC workflows. Implementing transparent reporting of DP data quality will enable researchers to exclude
artifacts from their training sets in a consistent cross-investigator manner. Our work will provide greater trust in
dataset reuse and experimental reproducibility while also easing AI/ML model creation and enhancing their
performance. We will build on strong preliminary data and prototypes, demonstrating both significantly improved
cross-reader QC reproducibility and technical feasibility, with three specific aims. Aim 1 sees this enrichment
process will be applied to WSI from NIH-supported public datasets, including TCGA and GTEx, and for NIH/NCI
Division of Cancer Biology research programs supported by the Multi-Consortia Coordinating (MC2) Center
parent grant. Aim 2 employs the lessons learned from the enhancement of raw DP data to be AI/ML ready in
Aim 1 to deploy a scalable workflow for QC of all incoming DP data from MC2-supported programs, providing
continual prospective data enrichment to assure AI/ML readiness. Lastly, Aim 3 demonstrates enhanced AI/ML
readiness of DP data subjected to our automated QC processes using a prototypical self-supervised tissue
classification task. Our deliverables include (a) 5000 WSI annotated by our QC workflow and enhanced into
AI/ML ready datasets; (b) workflows to enable processing of incoming datasets for AI-readiness, (c) a failure rate
of identifying poor quality slides is <1%; and (d) our QC comparative AI/ML demonstration yields an improvement
of >10% performance in terms of tissue classification performance as a result of our data enhancements.

Public health relevance
Project Narrative The project will improve the AI/ML readiness of existing and emerging NIH-supported digital pathology public datasets, and research programs supported by the MC2 Center, by automatically evaluating and reporting artifacts and batch effects using open-source NIH-funded tools. These enriched datasets will enable researchers to exclude artifacts from their training and validation sets in a reproducible manner, providing greater trust in cross-investigator dataset reuse while enhancing AI/ML model performance and robustness. To quantitatively demonstrate the provided value-add of cleaned AI/ML-ready data in downstream tasks, a prototypical deep learning use case is planned.